Using biomarkers to elucidate the breastfeeding and ovarian cancer risk association

ABSTRACT
Ovarian cancer survival is poor with a 5-year survival of less than 50% and has shown little improvement in the
past several decades. Prevention of ovarian cancer has been challenging due to the lack of truly modifiable
factors that reduce ovarian cancer risk. Breastfeeding is associated with decreased ovarian cancer risk; however,
little is known about the biologic pathways impacted by breastfeeding that leads to long-term reduction in ovarian
cancer risk. The goal of this application is to elucidate the association between breastfeeding and reduced
ovarian cancer risk by identifying factors that mediate and modify this association. While breastfeeding can cause
amenorrhea which decreases the lifetime number of ovulations, the observed protection exceeds what would be
expected by lactational amenorrhea alone. We hypothesize that breastfeeding alters the metabolic,
inflammatory, and immune environment both locally and systemically and these changes persist for years after
the exposure, leading to decreased ovarian cancer risk. To examine these mechanisms, we will leverage existing
detailed questionnaire data from two international consortia including 854,050 women across 22 studies (12
case-control studies including 9,357 cases, 12,425 controls and 10 prospective cohorts including 832,268
participants with 1,900 cases), circulating inflammatory and metabolic biomarker data measured in prospectively
collected samples from more than 7,000 participants in the Nurses’ Health Studies (NHS/NHSII), and ovarian
cancer tumor tissue marker data from 681 ovarian cancer cases in NHS/NHSII and the population-based New
England Case Control Study (NEC). This innovative project will leverage data from two international consortia,
blood biomarker data generated using reproducible validated assays, and tissue marker data using the cutting
edge, multiplex immunofluorescence platform that allows simultaneous consideration of multiple immune
markers. These extensive resources and rigorous methods provide a unique opportunity to investigate several
mechanisms that may help explain the long-term impact of breastfeeding on ovarian cancer risk reduction.
Results from this project will enhance our understanding of the underlying biologic pathways through which
breastfeeding reduces ovarian cancer risk, opening new avenues for ovarian cancer prevention research.
Importantly, findings from the proposed research have high potential to inform novel prevention strategies
through identification of key inflammatory, immune, and metabolic pathways modulated by breastfeeding and
thus greatly improve outcomes for women diagnosed with this deadly disease.

Public health relevance
NARRATIVE Ovarian cancer survival remains poor with a 5-year survival of less than 50%. Breastfeeding is associated with decreased ovarian cancer risk; however, little is known about the biologic pathways impacted by breastfeeding that leads to long-term reduction in ovarian cancer risk. The proposed study will elucidate this association by using circulating biomarkers, tumor marker expression, and detailed questionnaire data from more than 800,000 women, which will inform new avenues for primary chemoprevention targets and/or intervention strategies and further our understanding of ovarian cancer etiology.